Randomized Placebo-Controlled Trial of Methylphenidate for the Treatment of Post-Traumatic Stress Disorder with Associated Neurocognitive Complaints

Background: Posttraumatic stress disorder (PTSD) is a chronic psychiatric illness that is associated with
significant suffering and disability in Veterans. Current treatment options are not fully effective for all Veterans,
and even when they are effective in lowering total symptom burden, many Veterans continue to experience
significant symptom burden and associated functional impairment. Total symptom burden and associated
functional impairment is often particularly high for those with comorbid mild traumatic brain injury (mTBI).
Methylphenidate (MPH) is a widely available psychostimulant medication with a long track record of safety, which
has been used to improve cognitive functioning in attention deficit hyperactivity disorder (ADHD) and has also
shown benefit for mood and cognitive functioning in studies of moderate or severe TBI and as augmentation in
treatment-resistant major depressive disorder. In a small pilot study of the efficacy of MPH for subjective cognitive
impairment associated with PTSD and/or mTBI, members of our research team found that MPH resulted in not
only a significant improvement in subjective and objective measures of cognitive functioning, but also a
significant decrease in symptoms of both depression and PTSD.
Methods: Here, we propose to follow up this promising initial finding with an aggregated N-of-1 randomized
placebo-controlled trial of MPH versus placebo (PBO) for PTSD and cognitive symptoms in Veterans with PTSD,
with or without comorbid TBI. N=70 Veterans across two sites will each receive sequential 4-week periods of
MPH and PBO, in randomized order and separated by a 1-week washout, for a total of 20 weeks. During this
time, they will complete weekly or biweekly assessments. This trial design, which is particularly well-optimized
for conditions in which a heterogeneous response to treatment is expected, will let us achieve a number of
specific aims. First, we will assess the efficacy of MPH compared to PBO for reducing PTSD and depression
symptoms in Veterans with PTSD and neurocognitive complaints. Second, we will assess the impact of MPH
compared to PBO on neurocognitive functioning in this same population. And third, we characterize the baseline
predictors of treatment response to MPH in this population, including whether Veterans with a history of mTBI
show greater average treatment response to MPH versus PBO. Finally, this trial design will also allow a
systematic assessment of risks in this population, including the risk of discontinuation effects or loss of efficacy
over time.
Significance: MPH represents a well-tolerated medication with a novel mechanism of action compared to the
currently recommended and often ineffective pharmacologic treatments for PTSD and mTBI with associated
cognitive complaints. If the results of this study support the use of MPH to decrease PTSD and neurocognitive
symptoms in Veterans, it would provide an important new treatment option for Veterans with PTSD, which could
be rapidly integrated into clinical practice.

Public health relevance
Posttraumatic stress disorder (PTSD) is frequently accompanied by difficulty concentrating, poor memory, and inability to keep up with tasks, which negatively impacts a person's ability to function at work and in relationships. Currently available treatments do not fully relieve all symptoms. A published research report showed positive evidence that the stimulant medication methylphenidate was beneficial in treating these problems. This study will evaluate the ability of methylphenidate to treat PTSD and associated neurocognitive complaints in Veterans. An innovative feature is the study's N-of-1 design. In this design, every participant will move back and forth every 4-5 weeks between treatment with methylphenidate and treatment with placebo, in random order and under double-blind conditions, over a 20-week period. The investigators will compare the aggregated change in PTSD and neurocognitive symptoms between periods of treatment with methylphenidate versus placebo. Results will help clinicians to better choose the best treatment for Veterans living with PTSD.